Task-aware and Autonomous Robotic C-arm Servoing for Flouroscopy-guided Interventions

Project Summary
Fluoroscopy guidance using C-arm X-ray systems is used in more than 17 million procedures across the US
and constitutes the state-of-care for various percutaneous procedures, including internal ﬁxation of pelvic ring
injuries. To infer procedural progress from 2D radiographs, well-deﬁned views onto anatomy must be achieved
and restored multiple times during surgery. This process, known as ”ﬂuoro hunting”, is associated with 4.7 s
of excessive ﬂuoroscopy time per C-arm position (c. f. 120 s total per ﬁxation), yielding radiographs that are never
interpreted clinically, but drastically increasing procedure time and radiation dose to patient and surgical staff.
Our long-term project goal is to use concepts from machine learning and active vision to develop task-aware
algorithms for autonomous robotic C-arm servoing that interpret intra-operative radiographs and autonomously
adjust the C-arm pose to acquire ﬂuoroscopic images that are optimal for inference. We have three speciﬁc aims:
1) Detecting unfavorable K-wire trajectories from monoplane ﬂuoroscopy images: We will extend a physics-based sim-
ulation framework for ﬂuoroscopy from CT that enables fast generation of structured and realistic radiographs
documenting procedural progress. Based on this data, we will train a state-of-the-art convolutional neural net-
work that interprets ﬂuoroscopic images to infer procedural progress. 2) Developing and validating a task-aware
imaging system in silico: Using the autonomous interpretation tools and simulation pipeline available through
Aim 1, we will train an artiﬁcial agent based on reinforcement learning and active vision. This agent will be
capable of analyzing intra-operative ﬂuoroscopic images to autonomously adjust the C-arm pose to yield task-
optimal views onto anatomy. 3) Demonstrating feasibility of our task-aware imaging concept ex vivo: Our third aim
will establish task-aware C-arm imaging in controlled clinical environments. We will attempt internal ﬁxation
of anterior pelvic ring fractures and our task-aware artiﬁcial agent will interpret intra-operatively acquired ra-
diographs to infer procedural progress and suggest optimal C-arm poses that will be realized manually with an
optically-tracked mobile C-arm system.
This work combines the expertise of a computer scientist, a surgical robotics expert, and an orthopedic
trauma surgeon to explore the untapped, understudied area of autonomous imaging enabled by advances in
machine learning in ﬂuoroscopy-guided procedures. This development has only recently been made feasible
by innovations in fast ﬂuoroscopy simulation from CT to provide structured data for training that is sufﬁciently
realistic to warrant generalization to clinical data. With support from the NIH Trailblazer Award, our team
will be the ﬁrst to investigate autonomous and task-aware C-arm imaging systems, paving the way for a new
paradigm in medical image acquisition, which will directly beneﬁt millions of patients by task-oriented image
acquisition on a patient-speciﬁc basis. Subsequent R01 funding will customize this concept to other high-volume
procedures, such as vertebroplasty.

Public health relevance
Project Narrative Fluoroscopy guidance using C-arm X-ray systems is the state-of-care for percutaneous fracture ﬁxation, and requires surgeons to achieve and reproduce well deﬁned views onto anatomy to infer procedural progress. This requirement alone is estimated to contribute 4.7 s of ﬂuoroscopy time per C-arm repositioning (c. f. 120 s total per ﬁxation), drastically increasing procedure time and radiation dose to patient and surgical team. The goal of this project is to develop machine learning-based C-arm servoing algorithms that introduce task awareness by interpreting intra-operative radiographs and autonomously adjusting the C-arm pose to task-optimal views.